The role of DNA Polymerase Delta 4 in Lung Carcinogenesis Induced by Genotoxic Carcinogens

ABSTRACT
Lung cancer is the leading cause of cancer-related death in the world. Exposures to airborne carcinogens
contribute significantly to lung carcinogenesis. Genotoxic carcinogens, which can come from environmental
and/or occupational settings, are the most important causes of lung malignancy in humans. These include
hexavalent chromium (Cr(VI)), nicotine-derived nitrosamine ketone (NNK), benzo(a)pyrene (BaP), and urethane.
Exposure to these carcinogens can lead to formation of DNA adducts that induce DNA double-strand breaks.
DNA damage is a key early event and the driving force of genetic abnormalities that lead to malignant
transformation of normal lung epithelial cells. In humans, there are two forms of Polδ: Polδ4 and Polδ3. Polδ4
is a tetramer containing the p12 subunit which is absent in yeast. The degradation of p12 in response to DNA
damage leads to the conversion of Polδ4 to Polδ3. This is a novel cellular regulatory system that orchestrates
the formation of Polδ3 which plays a key role in DNA repair and replication. Our recent work shows that Polδ4
is the enzyme form that is involved in the key step in homology directed repair (HDR) of DSBs. Loss of Polδ4
leads to HDR deficiency and is a novel potential contributor to tumorigenesis. Our goals are directed to the
unexplored roles of Polδ4 loss in lung tumorigenesis. Our first aim is to characterize the effects of the lung
carcinogens (Cr(VI), BaP and NNK on p12 degradation in lung epithelial cell lines as well as the mechanisms
involved in this process. These studies have not been done in non-neoplastically transformed cells. We will study
the potential of chronic exposure to the above-mentioned carcinogens on p12 degradation, as well as their
capacity to lead to epigenetic changes that suppress p12 expression after chronic exposure. Our second aim is
to test the hypothesis that p12 depletion facilitates neoplastic transformation of lung epithelial cells. We will
examine whether p12 deletion promotes neoplastic transformation of lung epithelial cells induced by these
carcinogens. We will also investigate whether p12 deletion enhances the ability of urethane to induce lung tumors
to provide an in vivo readout of the effects of p12 on lung tumorigenesis. As deletion of p12 eliminates the
possibility of forming the Polδ4 enzyme, the p12 knockout cell and mouse models are absent of Polδ4. These
models thus have a unique and defined locus in the convergent step of D-loop extension, a crucial step in HDR.
The p12 knockout mouse model provides a unique opportunity to examine the role of p12 in lung carcinogenesis
induced by genotoxic carcinogens in vivo in a clean background. These studies will lead to evidence for a role
of Polδ4 in lung tumorigenesis that originates from a novel route to HR-deficiency and have the potential to open
up further avenues of research that could contribute to future therapeutic approaches in lung cancer.

Public health relevance
PROJECT NARRATIVE Homologous recombination DNA repair is critical for repairing DNA damage induced by genotoxic carcinogens. Defective DNA repair leads to carcinogenesis. This study will examine the role of Polδ4, an important mediator of this DNA repair process, in lung carcinogenesis induced by well-established lung carcinogens.